Population Genomics-Guided Dissection of the Bacterial Genetic Basis of Tuberculosis Transmissibility

PROJECT SUMMARY
Mycobacterium tuberculosis (Mtb) is one of the most persistent pathogens that has been transmitted within
the human population for millennia. The convention of this field has largely focused on understanding the
mechanisms of the virulence genes that make Mtb pathogenic. However, the bacterial genetic basis
underlying tuberculosis (TB) transmission—a critical aspect of TB epidemiology—remains understudied and
poorly understood. This knowledge gap exists because transmission is a population-level phenotype and
effective measurement tools have only recently become available. Whole-genome sequencing of Mtb strains
from population-based cohorts has enabled the assessment of transmissibility of different Mtb strains. My
research, alongside others, has shown that in various high-burden settings, the majority of ongoing TB
transmissions are driven by a small subset of Mtb strains have evolved to be highly transmissible. The
identification of highly transmissible strains and their phylogenetically neighboring low-transmissible strains
suggests transmissibility of Mtb is an evolving trait, offering a new research opportunity to study the bacterial
genetic basis underlying TB transmission.
In this proposal, I plan to apply a novel research framework that integrates population genomics and cutting-
edge experimental tools to investigate the bacterial genetic basis of high transmissibility. Specifically, (1) I
aim to identify key mutations driving high transmissibility in Mtb by leveraging a global collection of 120,000
Mtb genomes from 72 countries. Using population genomics approaches, I seek to identify convergent
mutations and common pathways evolved by highly transmissible strains from different countries. (2) I will
develop a novel high-throughput bacterial physiological profiling system to characterize the altered bacterial
functions in highly transmissible strains under various host-related conditions. (3) Building on my previous
findings, I will investigate the role of redox mutations (sseA and trxB2), evolved by highly transmissible strains
in Tibet and Peru, in promoting transmission by increasing resistance to reductive stress and facilitating
granuloma necrosis.
The primary goal is to identify common mechanisms evolved by highly transmissible strains in different
countries to enhance transmission. If successful, these insights can guide the development of new preventive
strategies tailored to halt the spread of these strains. My cross-disciplinary expertise in population genomics,
high-throughput bacterial phenotyping, and classical bacterial genetics uniquely positions me to execute the
planned research successfully. Additionally, the approaches developed in this project can be applied to
investigate other important bacterial pathogens. This project will also provide a fully genotyped and
phenotyped panel of highly transmissible strains as an open resource for other research groups to test new
interventions, such as antibiotics and vaccines.

Public health relevance
PROJECT NARRATIVE The ongoing transmission of TB is primarily driven by a subset of Mtb strains that have evolved an exceptional ability to transmit between humans, but limited knowledge of the underlying bacterial genetic factors hinders the development of effective strategies to halt TB transmission. This proposal will utilize a global collection of over 120,000 Mtb genomes and an innovative research framework to identify mutations and altered bacterial functions that enhance Mtb transmissibility, as well as investigate the impact of mutations in redox pathway on granuloma necrosis. By uncovering the evolved bacterial mechanisms that drive TB transmission, this work can identify novel targets for the development of intervention strategies specifically designed to target highly transmissible strains.